The role of VSMC-specific PERK in TMAO-induced abdominal aortic aneurysm

ABRTRACT (Project Summary)
Abdominal aortic aneurysm (AAA) is categorized as a progressive weakening and dilation of the aortic wall
resulting in chronic failure of the aortic wall and catastrophic rupture with mortality rates >80% resulting in the
death of ~30,000 Americans and ~500,000 people worldwide. Known risk factors for AAA include tobacco use,
hypertension, male gender, and cardiovascular disease, however, the underlying mechanisms of this disease
are still poorly understood. Moreover, little progress has been made in identification of druggable targets to
reduce AAA burden creating a void in patient care. Pharmaceuticals (statins, ACE inhibitors) against CVDs have
had limited success in AAA patients and the only treatment option is invasive surgical intervention, pursued only
when the risk of aneurysm rupture outweighs the risk of surgery. Recent evidence has emerged demonstrating
that resident gut microbes in the human intestine can promote several cardiovascular diseases. Specifically, the
meta-organismal produced metabolite trimethylamine N-oxide (TMAO) has repeatedly been linked to numerous
cardiovascular and metabolic pathologies. Our previous work demonstrates that TMAO is associated with AAA
status in two case/control cohorts. Furthermore, dietary choline increases circulating TMAO in a gut microbiome
dependent manner to enhance AAA pathogenesis in murine models. The putative receptor for TMAO is the
endoplasmic protein kinase R (PKR)-like endoplasmic reticulum kinase (PERK), known as an initiator of the
unfolded protein response (UPR) and endoplasmic reticulum (ER) stress. PERK signaling temporally regulates
autophagy, apoptosis, mitochondrial-ER contact points (MERCs), and mitochondrial function, processes that are
all affiliated with AAA pathogenesis. Our preliminary data demonstrates that both in vivo choline-induced TMAO
and ex vivo application of TMAO result in PERK-dependent ER-stress. Additionally, TMAO treatment induces
loss of VSMC phenotype, increases apoptosis, and blunts autophagy in a PERK-dependent manner. Yet, the
contribution of TMAO-mediated PERK activation in VSMCs to AAA initiation and progression remains uncertain.
Thus, the overall goal of this proposal is to determine how the gut microbiome-derived metabolite TMAO
contributes to the initiation and progression of AAA through its putative binding target PERK. Our two specific
aims will (1) define the role of VSMC-specific PERK in TMAO-augmented AAA; and (2) determine the PERK-
dependent detrimental mechanisms in VSMCs. Successful completion of this F32 research proposal will
increase our understanding of the of the mechanisms by which TMAO-mediated PERK signaling exacerbates
AAA initiation and progression in order to identify novel therapeutic targets for the prevention and treatment of
AAA in patients. The experience gained from this proposal under the mentorship of Dr. Owens and my advisory
committee at the University of Cincinnati will facilitate my transition into an independent investigator.

Public health relevance
PROJECT NARRATIVE: RELEVANCE TO PUBLIC HEALTH Abdominal aortic aneurysm (AAA) is characterized by progressive deterioration of the aortic wall and catastrophic aortic failure resulting in sudden death in >80% of acute ruptures leading to the death of ~30,000 Americans and ~500,000 people worldwide. Unfortunately, there are no pharmacological treatments available for the prevention of AAA progression and rupture and the only option for these patients is surgical intervention. Our proposal seeks to investigate the mechanisms by which trimethylamine N-oxide (TMAO) activation of its putative binding target protein kinase R (PKR)-like endoplasmic reticulum kinase (PERK) contributes to vascular smooth muscle cell (VSMC) dysfunction and subsequent initiation and progression of AAA to elucidate novel therapeutic targets for this lethal disease.